OTHER FUNCTIONS: PHASE I SBIR CONTRACT, DRUGGED DRIVING NATIONAL DATA RESOURCE.

The goal of this project is for NRI and UCLA to develop a National Network on Drugged Driving (NNODD) website. The website will have an epidemiology component consisting of point prevalence and continuous monitoring data.